Measuring Veterans' Safe Patient Handling and Mobility Experiences

Background: Safe Patient Handling and Mobility (SPHM) consists of ergonomic techniques and equipment to
move patients who cannot move independently. SPHM helps minimize adverse events (pressure ulcers, falls),
and staff injuries. Despite benefits, we know little about how patients experience assisted mobility. With valid
and reliable scales, we can measure patient experiences, thus facilitating improved care, more tailored
evaluation, and more targeted clinical staff education. Patients in rehabilitation are an ideal group to study.
Specific aims: We will develop a valid and reliable self-report survey based upon patients' experiences of
assisted mobility: the (PEAM). We have three aims. First, the analysis of qualitative interview data will identify
and describe important concepts of patients' experiences. Scales and items will be generated from the
interviews. The items will be reviewed by patients and subject experts, assuring content validity. Second, the
PEAM will be fielded and the data analyzed to provide support for reliability and construct validity. Third, we will
examine the statistical relation between PEAM and associated outcomes to establish criterion validity.
Significance: Patient experiences of care are one of the pillars of health care quality. Yet, no measures
assess patients' perceptions of assisted mobility. The VA national directive for SPHM mandates program
evaluation, yet the Voice of the Veteran is not part of the assessment. The sheer number of rehabilitation unit
Veterans calls for their input. The PEAM will provide a valid and reliable measure to address this gap. PEAM
will allow identification of best practices, areas in need of improvement, and clinical staff educational priorities.
Priority domain: Our study addresses the HSR&D priority of patient-centered care and care management. We
examine how methods of care delivery can influence Veterans' experiences and relevant outcomes.
Innovation: PEAM will be the first reliable and validated patient-report survey of assisted mobility experiences.
Methodology: For Aim 1, we will conduct telephone interviews with 60 Veterans discharged from inpatient
rehabilitation units including: SCI, acute rehabilitation, short-stay nursing homes, and polytrauma. We will
interview 30 staff at two medical centers about their experiences with SPHM. Our conceptual model and
interview questions consist of patient, provider, equipment, environment, and task concepts. We will apply
thematic analysis to data to develop and refine constructs. An expert panel will evaluate item fit to constructs.
We will interview up to 15 Veterans to ensure items are understood as intended. For Aim 2, we will test the
instrument with a sample of Veterans (n=800). Item response theory and confirmatory factor analysis will
identify the best performing items. We will assess construct validity between the PEAM and other validated
measures. For Aim 3, we will assess criterion validity through field-based observational assessments and
surveys of Veterans (n=3500) at more than 20 facilities. We will model the relation between patient and unit
characteristics with PEAM. We will also examine patient and unit-level outcomes to establish criterion validity.
Expected results: Our resultant instrument will provide a unique measure of assisted mobility for this
understudied population and assess an important, yet understudied, aspect of the care recovery process.
Next steps: VA operational partners – including SCI/D and SPHM – will be provided with findings, insights,
and recommendations that can support evaluation from their directives. PEAM use in evaluation programs
nation-wide can be planned. Enriched evaluation using the PEAM by program offices could lead to changes in
policies, staff education, equipment, and improved care. Through individual feedback to facilities in Aim 3,
performance improvement efforts can be tailored around specific findings. We will work with program offices to
develop and implement tablet-based data collection methods. With a validated instrument, we can also include
the PEAM in surveys that VA regularly administers to assess patient experiences of rehabilitation care. Work
can also adapt the instrument for bariatric patient handling and long-term care priority areas.

Public health relevance
Hospitalized Veterans and groups representing Veterans have voiced concerns with aspects of patient assisted mobility (i.e. being moved via the use of equipment and technology). The study aims to develop and validate the patient experiences of assisted mobility (PEAM) instrument. The measure will help VA better understand Veterans' experiences, identify ways to improve safety, comfort, dignity, and mobility. We will conduct interviews with staff and Veterans receiving care at rehabilitation units: spinal cord injury; hospital- based acute rehabilitation; and short-stay nursing homes. We will identify important characteristics informed by our conceptual model. We develop a survey, review with our advisory panel and Veterans, and administer the survey twice with 800 and 3500 Veterans, conduct observation assessment. Analysis at each stage will help refine the instrument. We will examine how well PEAM relates to similar constructs and outcomes for both individual and the units providing care.